Longitudinal Modeling of Interpersonal Stress Induced Rumination to Understand Depression Risk in Adolescent Girls

PROJECT SUMMARY
Rates of major depressive disorder (MDD) sharply increase in adolescence, particularly for girls, with
approximately 30% of girls experiencing an episode of MDD by adulthood. Stress-reactive rumination (SRR),
the tendency to engage in rumination following the experience of stress or negative events, has been identified
as a specific mechanism of depression risk for adolescent girls that may be an important target for intervention.
Yet, progress in translating this research to targeted prevention and intervention efforts is hindered by a lack of
understanding of 1) the precise neural and behavioral mechanisms through which SRR eventuates in future
youth depression risk, 2) how these processes unfold over time in real-world settings, 3) key factors that
promote or mitigate altered SRR patterns and future depression in adolescent girls, and 4) how and when
changes in SRR over development, versus a single time point, correspond to changes in depression during
adolescence. Addressing these questions is pivotal for determining which adolescent females should be targeted
with prevention or intervention efforts aimed at modifying SRR patterns and identifying optimal windows for
intervention. The current R01 will employ a novel, multimodal, longitudinal study to test whether alterations in
cognitive-affective brain networks (salience emotional, cognitive control, and default-mode networks) during
stress-induced rumination predict future depression trajectories in adolescent girls (Aim 1). To increase the
ecological validity and applicability of this work, we will also test if naturalistic (ecological momentary assessment,
EMA) experiences of stress reactive rumination in response to day-to-day stressors predict increases in daily
depressive symptoms (Aim 2). We will assess factors that protect against (i.e., family cohesion) or exacerbate
(i.e., early life adversity) alterations in stress-reactive rumination development and subsequent depression to
identify adolescent girls who could most benefit from targeted interventions (Aim 3). Finally, by adding three time
points of neuroimaging, EMA, and depression assessments, we will build on prior work by studying trajectories
of change (and predictive modeling) in rumination across naturalistic and brain levels (Aim 4). To achieve these
aims, we will leverage our unique access to risk-enhanced youth in Columbus to recruit 210 youth females aged
10-14. At baseline, 12- and 24-months, youth will complete a reliable stress-induced rumination task during
magnetic resonance imaging and resting-state scan to measure key cognitive-affective brain networks. Each
imaging time pointed is time-locked to the 14-day EMA protocol to capture rumination and other coping strategy
use following daily stressors. Family relationship quality and cohesion and child early life adversity exposure at
individual and community-levels will be assessed at every time point, along with parent, youth, and clinician-
rated assessments of child’s depressive symptoms and disorders. Findings from the project may lead to novel
stress-reactive rumination prevention programs that could be delivered during early adolescence prior to the
emergence of depression to break risk cycles more effectively.

Public health relevance
PROJECT NARRATIVE Interpersonal stress-reactive rumination is an established risk factor for depression among adolescent girls; however, the precise mechanisms through which rumination eventuates in depression for this vulnerable population remain unclear. Combining multimodal measurements of stress-reactive rumination across three time points will answer critical questions about how stress-reactive ruminative trajectories across brain and naturalistic (ecological momentary assessment) units leads to depression in adolescent girls, and also explore how early life adversity and familial support might potentiate or buffer these pathways. The study has significant potential to inform novel prevention and intervention targets for specific populations of adolescent girls.